Biospecimen Core

PROJECT SUMMARY/ABSTRACT
The Biospecimen and Pathology Core of the Mayo Clinic Breast Cancer SPORE provides an expert
centralized pathology consultative service and a comprehensive resource of breast tissues, blood and “living
samples” for preparation of organoids and patient-derived xenografts, linked to epidemiological and clinical
data. The Core also curates clinically derived benign and neoplastic breast tissue samples with detailed
clinicopathological evaluation (e.g., stage, histologic features, clinical and emerging biomarker assessments) to
establish registries and cohorts for research. Samples collected include fresh, fresh-frozen, cryopreserved and
formalin-fixed paraffin embedded specimens from 1) treated or untreated breast cancers with mapped
background “benign-adjacent” tissues, 2) lymph node metastases and distant metastases, 3) benign breast
disease tissues across the spectrum of pre-neoplasia and 4)“normal” breast tissue harvested from
mammoplasty/risk reduction specimens from patients with or without clinical or genetic “high-risk” factors (e.g.
known germline BC predisposition gene mutations), as well as blood. The Core performs expert pathological
evaluation of research- related histopathological parameters (e.g., atypia in benign breast disease, involution
status of breast lobules, histologic subclassification of TNBC, evaluation of tumor response to neoadjuvant
therapy, stromal and intratumoral TIL scoring). In addition, the Core performs antibody optimizations as
required by the SPORE projects (e.g. PKCBeta1), followed by interpretation and scoring of these
immunohistochemical stains, and application of digital image-based approaches (e.g., optimization and
interpretation of digital image analysis algorithms with Aperio (Leica) (or HALO (Indica Labs) software systems,
high-plex quantitative digital spatial profiling (e.g. Nanostring GeoMX™ platform) for SPORE projects. The
Core coordinates with the Mayo Biospecimen Accessioning and Processing (BAP) Shared Resource to store
fresh-frozen and cryopreserved specimens and to process blood samples to provide genomic DNA and serum
and plasma aliquots; it collaborates with the Mayo Pathology Research Core (PRC) Shared Resource to obtain
essential technical tissue-based services including conventional and cryostat tissue sectioning,
immunohistochemistry, tissue microarray construction, slide scanning and cytotechnologist assistance for
optimizing digital imaging algorithms. Partnering with these institutional shared resources minimizes
redundancy of services and capitalizes both on technical experience and state-of-the-art technologies.

Public health relevance
NARRATIVE The Core procures biospecimens (snap-frozen, fresh, cryopreserved and FFPE benign and malignant tissues, and whole blood), provides expert histological characterization of both clinically-established and research- based pathologic features, accrues and designs tissue-based benign and breast cancer-associated cohorts, performs high volume assessment of clinical and research-based biomarkers, and employs digital image- based technologies and high-plex quantitative spatial profiling technologies to support breast SPORE projects and other breast cancer translational research projects. These functions are essential for successful translational research, including the projects described in this proposal.